Development of immune evasive strategies for allogeneic cell replacement therapies

Project Summary
Cell therapy is a promising new modality to treat, and potentially cure, a variety of diseases. There are
currently over a dozen cell therapy products approved by the FDA addressing a variety of diseases including
cancer, Type 1 diabetes, and sickle cell disease. However, most of these approaches involve autologous cell
transplants, which face challenges including unscalable manufacturing and complex logistics, impeding
widespread accessibility. There is therefore a critical need to develop new approaches, such as allogeneic
cell transplants, to lower costs and broaden access to these potentially curative therapies.
Pluripotent stem cells represent a promising approach to allogeneic cell therapy by providing an
unlimited supply of cells and the ability to differentiate to any cell type. A key limitation, however, is host
immune rejection of the stem-cell derived product upon transplantation, which currently necessitates lifelong
use of immunosuppressive drugs, which can be toxic.
Thus, Aleutian Therapeutics (Aleutian) is developing an immune evasion technology using gene
editing to overcome the current limitations of stem-cell derived cell therapies. Aleutian’s innovative novel
technology involves gene editing of pluripotent stem cells so that stem cell-derived cell therapies can be
transplanted without the need for immunosuppressive drugs. Aleutian’s academic collaborator has previously
conducted animal studies demonstrating that a panel of 12 genetic edits is sufficient to enable human
pluripotent stem cells to overcome the xenogeneic barrier and survive for nearly six months in fully immune
competent mice. The objective of the proposed Phase I research is to ascertain the minimal number of edits
required to overcome the xenogeneic complement and NK (natural killer) barriers. Extensive preliminary data
suggest the inhibition of T cells, NK cells, and complement are essential to overcoming the xenogeneic barrier
in mice.
Specific Aim 1 focuses on determining the minimal edits required for protection from complement-
dependent cytotoxicity, evaluating whether a single edit with human complement receptor type 1 (hCR1)
suffices. Specific Aim 2 will identify the most effective genetic modifications for evading NK cell-mediated
rejection, particularly investigating roles of H2-Kb and Qa1 proteins in a human pluripotent stem cell knockout
background. Specific Aim 3 aims to combine these findings to develop a stem cell line with minimal genetic
edits necessary for immune evasion, validated through in vivo testing in B cell-deficient mice.
Successful completion of the proposed Phase I study will show the minimum number of edits required
to achieve an immune evasive phenotype, which will inform Phase II pre-clinical studies.

Public health relevance
Project Narrative The development of immune-evasive stem cells through gene editing has significant implications for healthcare by expanding access and reducing risks associated with therapeutic cell transplants. Cell therapies have demonstrated success in autoimmune disease, Type 1 diabetes, cancer, among others, but current technologies suffer from unscalable manufacturing, poor durability, or a requirement to administer toxic immune suppression drugs. Aleutian is developing a panel of genetic edits in stem cells that have the potential to enable scalable manufacture of universal donor cells and administration of these cells for therapeutic applications without the need for immunosuppressive drugs.